MHC-Restricted and MHC-Non-Restricted Targeting of Ovarian Cancer by alphaDC1

Genomic instability of ovarian cancer (OvCa) cells and the resulting frequent loss or reduction of HLA expression and function facilitate immune avoidance of this aggressive cancer. The goal of this Project is to develop an effective mode of immunotherapy capable of targeting both MHC-positive and MHC-negative variants of OvCa and counteracting local immune suppression, known to contribute to poor prognosis in OvCa patients. We observed that type-1-polarized DCs (αDC1s), a novel type of DCs developed by our group, effectively cross-present OvCa-related antigens and induce high numbers of MHC class l-restricted CTLs capable of recognizing defined OvCa-related antigenic epitopes. However αDC1-induced CTLs also express elevated levels of NK receptors, NKG2D- and DNAM1. Such NK cell-like (n)CTLs recognize OvCa cells in both MHC class l-restricted- and MHC class l-unrestricted fashion. IFNγ produced by αDC1-activated nCTLs has a strong positive impact on OvCa microenvironment, suppressing the chemokines that attract undesirable Treg cells and MDSCs and enhancing the production of the chemokines that attract additional effector cells. Based on these preliminary data, we hypothesize that autologous tumor-loaded αDCIs used both as vaccines and as ex-vivo inducers of OvCa-specific CTLs for adoptive T cell transfer in OvCa can be useful in the immunotherapy of patients treated with primary chemotherapy (which may sensitize tumor cells for the NKG2D- and DNAM-1-mediated recognition). We will test the hypothesis that local adoptive transfer of ex-vivo-sensitized (n)CTLs will amplify the effects of systemic vaccination against OvCa, by promoting direct elimination of residual tumor cells and the attraction of additional (vaccination induced) T cells. In Specific Aim 1, we will evaluate the mechanisms involved in the induction of OvCa-specific NKG2D{high}/DNAM-1{high} (n)CTLs by αDCIs and the mechanisms of their TCR-dependent and TCR-independent recognition and killing of OvCa cells. In Specific Aim 2, we will evaluate the regulation of the NK cell-type receptors ligands (MICA/B, ULBP1-6, PVR/CD155 and Necfin-2/CD112) on OvCa cells by chemotherapy, CTL/NK-produced cytokines and additional clinically-applicable biologic agents, and will evaluate the potential for additional sensitization of OvCa cells for (n)CTL-mediated killing. In Specific Aim 3, we will evaluate in phase I clinical trial (24 high-risk patients with advanced primary OvCa) the feasibility and safety of combined immunotherapy of advanced OvCa involving vaccination with autologous tumor-loaded αDCIs and intraperitoneal adoptive transfer of increasing numbers ex-vivo-induced OvCa-specific (n)CTLs, in the context of systemic and intraperitoneal chemotherapy.

Public health relevance
We plan to develop a new immunotherapy of ovarian cancer, combining a new highly-potent autologous dendritic cells vaccine (αDC1s) with the local infusion of ex-vivo αDC1-induced effector CD8+ T cells (CTLs) able of recognizing tumor cells both in a classical (TCR-dependent) and TCR-independent manner. We anticipate that such treatment will promote destruction of residual tumor cells in patients with advanced ovarian cancer treated with chemotherapy, independently on their ability to mutate and evade classical forms of immune recognition, preventing or delaying tumor recurrence.